Exploring Feasibility of Gene-Targeted Therapeutics for Epigenetic Neurodevelopmental Disorders

PROJECT SUMMARY
The identification of hundreds of genes associated with autism and related neurodevelopmental diseases
(ASD/NDDs) in recent years has created and opportunity to leverage genetic discoveries into therapeutics for these
disorders. Classically ASD/NDDs were assumed to be intractable due to disrupted development in utero, but
studies in mice have demonstrated that restoring gene activity after birth can likely ameliorate phenotypes in
some prominent ASD/NDDs. These findings create an imperative to systematically test the feasibility of
genetically targeted therapies across ASD/NDDs with distinct genetic causes, but limited studies of this type
have been carried out to date. A major class of disorders that has yet to be investigated in this paradigm is
ASD/NDD caused by mutation of “epigenetic writer” enzymes. These enzymes chemically modify chromatin and
DNA to control gene expression during development and throughout life. While the important potential role of
these genes in early cell fate and patterning has suggested it will be it difficult to correct defects after altered
development, recent studies have uncovered postnatal functions for these factors that are likely to be drivers of
phenotypes in ASD/NDD. Therefore, in the proposed studies we will develop enabling mouse transgenic
reagents to investigate the tractability of genetic rescue of ASD/NDDs caused by mutation of epigenetic writers.
Our previous studies that have uncovered postnatal functions for the ASD/NDD-associated writer DNA
methyltransferase 3A (DNMT3A) and defined robust phenotypes in heterozygous mutant mice the mimic human
DNMT3A ASD/NDD mutations. We will therefore investigate the tractability of genetic reinstatement of the
DNMT3A gene for rescue of molecular and organismal deficits in mice. We will implement a newly-established
DNMT3A conditional genetic rescue strain to test the requirements for timing of DNMT3A reinstatement
necessary to rescue molecular deficits in vivo (Aim 1). We will then perform proof-of-principle studies to
investigate the degree to which behavioral and physiological function can be rescued by gene reactivation (Aim
2). Together these studies will establish enabling technologies and essential proof-of-principle findings to guide
future large-scale development gene targeted therapeutics in DNMT3A disorders. Furthermore, by assessing
the tractability of reinstatement for epigenetic writers in ASD/NDD, our studies can motivate therapeutic research
efforts across a broad class of genetic causes for these disorders, advancing toward treatments for these
devastating conditions.

Public health relevance
PUBLIC HEALTH RELEVANCE Published estimates indicate that 1 in 44 children are diagnosed with Autism Spectrum Disorder (ASD) (https://www.cdc.gov/), and while many genetic causes of ASD and related neurodevelopmental disorders have now been discovered, these discoveries have not yet been translated into gene-based treatments for these disorders. This project will use a newly developed mouse strain to test the feasibility of reinstating the function of the DNMT3A gene in order to treat neurodevelopmental disorders caused by mutation of this gene. This work will establish new tools to study therapeutics for DNMT3A-associated disorders and provide fundamental insights into the feasibility of treating an entire class of neurodevelopmental disorders caused by disruption of “epigenetic writer” genes that are related to DNMT3A.